STRUCTURAL STUDIES ON HEME BIOSYNTHETIC ENZYMES

Understanding of the heme biosynthetic pathway, which is essential in all organisms is currently limited by lack of structural data for the relevant enzymes. This proposal is for structure-function studies on the enzymes uroporphyrinogen decarboxylase (URO-D) and coproporphyrinogen oxidase (COPRO-OX), which catalyze successive steps in the heme biosynthetic pathway and are both associated with human diseases. Our goal is to obtain high resolution structural information by X-ray crystallography and to elucidate catalytic mechanisms by structure-based mutagenesis and biochemistry. Toward this goal we have recently determined the crystal structure of URO-D by multiwavelength anomalous diffraction at 2.0 Angstrom units resolution. Mutagenic and biochemical studies are proposed to elucidate the role of individual residues in binding and catalysis. The URO-D crystal structure reveals a dimeric arrangement that juxtaposes the deep active site clefts, and we have shown that URO-D has a 0.1 muM dissociation constant in solution. In order to test the hypothesis that URO-D dimerization is of functional importance, we also propose mutagenic and biochemical studies to determine the role of dimerization in URO-D activity. We will also determine the crystal structures of relevant URO-D mutants and inhibitor complexes. We have obtained crystals of yeast COPRO-OX and collected X-ray diffraction data to 3.0 Angstrom units resolution. This structure will also be determined and will be used to design site-directed mutants to probe the roles of specific residues. Deficiency in URO-D and COPRO-OX activities cause the disease porphyria cutanea tarda and hereditary coproporphyria, respectively. The combination of proposed structural and biochemical studies may provide the basis for the design of novel therapeutics.